Neural mechanisms of specificity and generalization learning

Project summary
Memory-based cognition depends on both the ability to remember specific details of individual experiences
(specificity) and the ability to combine information across experiences to derive new knowledge
(generalization). It is well established that the hippocampus rapidly encodes specific events, but the
mechanisms of memory generalization are less clear. Traditionally, a division of labor has been postulated
between the hippocampus, learning rapidly to support specificity, and other memory systems, learning slowly
and incrementally to support generalization. More recent research has also shown a role of the hippocampus
in rapid generalization, where new knowledge is derived by combining information across a small number of
events. It is currently debated whether the hippocampal contribution to generalization is fully explainable by its
role in storing specific experiences or whether the hippocampus integrates information across experiences to
form generalized knowledge. Furthermore, it is unclear whether generalization learning proceeds at the
expense of memory for specific details or whether multiple types of memory representations form and co-exist
to serve multiple forms of cognition. The current project tests the hypotheses that representations at distinct
levels of specificity form in parallel along the long axis of the hippocampus through interactions with distinct
cortical regions. More anterior generalized representations inform generalization. More posterior specific
representations support memory specificity but can also inform generalization decisions under circumstances
when generalized representations have not been formed. To test these hypotheses, the proposed studies use
functional MRI in humans during concept-learning tasks in which both specificity and generalization learning is
indexed using (1) behavioral methods, (2) cognitive modeling and model-based fMRI, and (3) neural pattern
similarity analyses. The studies will determine the mechanism(s) of memory generalization and how it relates
to memory for specific events, the degree to which the formation of distinct representation is under strategic
control, and the hippocampal-cortical interactions that contribute to specificity and generalization learning. The
results will reveal whether specificity and generalization are two behavioral expressions supported by a single
neural representation, a single neural system that can form different types of memory representations under
different task demands, or distinct neural systems that form distinct representations. The results will inform
current theories of memory function and help reconcile a decades-long debate regarding the nature of concept
representations. In this supplemental application, we request funding for research experience for Troy Houser,
a graduate student in the Brain and Memory lab of the PI Dr. Zeithamova. The supplementee will conduct
novel analyses addressing alternative hypotheses regarding the organization of specific and generalized
memory representations within hippocampus, and receive training in fMRI analyses and grant writing.

Public health relevance
Memory allows us to remember specific past experiences, but also find commonalities across experiences generalizable to novel situations. The proposed research will improve our understanding of mechanisms supporting memory specificity and generalization, their contribution to decision-making, and their implementation in the healthy brain. These findings will generate new predictions about the causes of a wide variety of memory impairments, such as reduced memory specificity in aging and Alzheimer’s disease, imbalance of specificity and generalization learning in anxiety, depression, and autism, and mixed patterns of impairments following a stroke.